Histotools: scaling digital pathology curation tools for quality control, annotation, labeling, and dataset identification

ABSTRACT: With recent approval of whole slide scanners for primary diagnosis, wherein routine glass
histopathology slides are digitized and presented to clinical pathologists for diagnosis on computer monitors, a
wealth of new untapped data is being created in routine clinical practice and placed in growing data lakes. In
digital format, these whole slide images (WSIs) can be subjected to digital pathomics, i.e., the process of
extracting quantitative image features associated with morphology, attributes, and relationships of histologic
objects in WSIs. These features can subsequently be employed for discovery in many domains such as
histogenomics, which sees associating phenotypical presentations with biological pathways and gene
ontologies. Additionally, low-cost non-tissue destructive image-based companion diagnostic assays (CDx)
can be developed for predicting prognosis and treatment response of patients. Unfortunately, unprocessed large
data lakes (e.g., TCGA) are not alone sufficient for pathomics, and often require an intractable amount of human
curation effort in (i) performing meticulous quality control of WSI (i.e., avoid “garbage-in, garbage-out”) and
subsequently (ii) precisely annotating (e.g., cell boundary) and labeling (e.g., cell type) histologic objects. To
address these major limiting factors in curating data lakes, we propose developing our small-scale HistoTools
prototypes to employ computing clusters and thus enable their function at the scale of large digital slide
repositories (DSR): (i) HistoQC for robust, reproducible quality control of WSI by identifying artifacts (blurriness)
and outliers (poorly stained slides) for avoidance in downstream analyses, (ii) CohortFinder for identification
and compensation of batch affects, (iii) Quick Annotator for rapid computer aided annotation generation via a
combination of active and machine learning, (iv) PatchSorter for improving sub-typing of histologic objects with
machine learning. We will evaluate HistoTools for improvement of quality control and the efficiency of both
segmenting and labeling histologic objects of interest via (a) onsite curation and release of the 14k WSI used
during our internal validation and (b) supported external curation of at least 100k WSI via 24-clinical affiliates
from every continent, except Antarctica, whom together have access to over 20 million WSI during this proposal.
Our validation use cases are designed to expedite existing onsite projects in the CDx space, consisting of 4
organs (breast, lung, heart, kidney), 3 diseases (cancer, kidney disease, and organ rejection) and WSIs collected
from >70 sites. These cohort characteristics will help ensure the generalizability of our tools for curated data lake
creation, with open-source and usability study approaches employed to obtain feedback from collaborators and
the larger research community. Dissemination through consortia (ITCR, NEPTUNE) and websites (Github, TCIA)
will improve visibility and adoption. The tools and well-curated data sets we release are anticipated to bootstrap
researcher-initiated CDx discovery projects, along with the creation of their own onsite manicured data lakes.
Together, this proposal will engender digital pathology based precision medicine research.

Public health relevance
RELEVANCE: This project will result in the development of cluster/cloud scale HistoTools to enable curation of large-scale digital slide data lakes via (a) timely identification of poor-quality slides and slide regions, (b) quantitative metrics driving optimized cohort selection for compensation of batch effects, and (c) generation of highly precise and relevant object annotations and labels. The employment of HistoTools will facilitate (a) the creation of companion diagnostic assays in the cancer, kidney disease, and heart rejection space via curation and release of over 14k WSI, and (b) external collaborators validating the tools on 100k WSI, thus helping drive global onsite curation of well-curated data lakes.